Identification of small molecule that selectively modulate Ghrelin receptor (GHSR1a) b-arrestin signaling as a new therapeutic approach for the treatment of addiction

During this period, the project team focused on characterizing a molecule that was identified by high-throughput screening and lead optimization. Ghrelin receptor pharmacology was characterized by measuring G protein activation, B-arrestin recruitment, and endosomal trafficking. Binding to the receptor is being assessed using a combination of in silico modeling, mutagenesis, and biophysical approaches. To continue characterization of the lead compound, the collaborating laboratories have formed an interdisciplinary team with extensive expertise in drug discovery, biochemical and behavioral assays of GPCRs, and testing of drugs in animal models of addictive behaviors in wild type and genetically modified mice.